Uncovering the Role of the MS4A Gene Family in Alzheimer's Disease

PROJECT SUMMARY
Alzheimer’s disease (AD) is a grave neurodegenerative disorder characterized by unrelenting memory loss and
deficits in executive function with no effective treatment. Accumulating evidence from genome wide association
studies (GWAS) posit that the brain’s innate immune system plays a central role in AD etiology. As the central
nervous system’s resident immune cells, microglia have thus emerged as attractive cells to target therapeutically.
Such drug targets may lie within the MS4A locus, a region associated with protection from AD, later age-at-
onset, and increased levels of sTREM2, a biomarker of microglial activity. This region contains multiple genes
within the membrane-spanning 4-domain subfamily A (MS4A) gene cluster, which together encode structurally
related transmembrane proteins largely expressed by immune cells whose exact functions are not yet
understood. Our work nominated a candidate causal variant within this locus, rs636317, which disrupts an anchor
binding site for the chromatin remodeling protein CTCF and is associated with increased expression of MS4A4A
and MS4A6A in myeloid cells. This proposal aims to directly test the hypothesis that by modulating MS4A4A and
MS4A6A expression via differential CTCF binding, variant rs636317 alters microglial cell function in the context
of disease. In AIM 1, I will determine the functional impact of MS4A genes in vitro using CRISPR-edited human
induced pluripotent stem cell (iPSC)-derived microglia (iMGL). Given known interactions between MS4A proteins
and other immune receptors such as TREM2 and CLEC7A, I will perform targeted functional assays related to
immune signaling in iMGLs from two iPSC models: MS4A4A/MS4A6A knockout lines and isogenic lines
homozygous for the protective or risk alleles of the candidate causal variant. In AIM 2, I will employ a novel
xenotransplantation model involving direct injection of human microglia precursor cells into the mouse brain to
evaluate the effect of these genes on cell function in vivo and in the context of disease using 5xFAD chimeric
mice. I hypothesize that knocking out MS4A4A and MS4A6A in human microglia promotes protective microglial
responses, ameliorating plaque containment and subsequent cognitive decline. Elucidating the function of this
gene family and the specific role it plays in AD progression has the potential to greatly impact public health. The
proposed research and rigorous training plan outlined here will equip me with the skills needed for a successful
future career in neurodegeneration leading an independent research team.

Public health relevance
PROJECT NARRATIVE The growing need for identifying effective therapeutics for Alzheimer’s disease (AD) can be met by bettering our understanding of the biological mechanisms by which genetic variants modify disease risk. By combining human induced pluripotent stem cells and an innovative xenotransplantation method, this proposal seeks to investigate the impact of a candidate risk variant in the MS4A locus and its causal genes on the function of disease- implicated microglia. This study will provide a blueprint for translating findings of genomic studies from statistical associations to biological function and serve to elucidate the contribution of MS4A genes to disease susceptibility, suggesting a mechanism of action that can be used for future drug discovery.